The Role of Abnormal Inter-Organelle Communication in the Pathogenesis of Tauopathy

PROJECT SUMMARY
Hyperphosphorylation and aggregation of microtubule-associated tau is a pathological hallmark of tauopathies,
which constitutes one of the two defining features of Alzheimer’s disease (AD). In AD, tau pathology correlates
with neuronal death and cognitive dysfunction better than amyloid plaques. Thus, understanding the pathogenic
mechanisms underlying tau buildup and toxicity is of great importance in developing tau-targeting therapy for
treating AD and other tauopathy diseases. Pathologically phosphorylated tau (p-tau) is known to be degraded
within lysosomes after sequestration within autophagosomes/autophagic vacuoles (AVs). Earlier studies of
tauopathy patient brains demonstrated autophagy abnormalities—aberrant accumulation of AVs, suggesting
autophagy failure in the removal of p-tau as a fundamental component of pathological progression. The
underlying mechanism, however, remains elusive. Recent breakthroughs in the field make it increasingly
evident that organelles engage in extensive communication through membrane contacts, and that deregulation
of inter-organelle communication is an emerging mechanism underlying aging and neurodegeneration. Our
preliminary findings revealed, for the first time, that AVs were accumulated at the synaptic terminals of
tauopathy brains. Most interestingly, these AVs were loaded with p-tau, in close contact with mitochondria, and
became immotile, which likely prevents AV retrograde transport and cargo clearance in tauopathy neurons. This
AV-mitochondria (Mito) contact hyper-tethering was associated with reduced expression of the contact release
factor TBC1D15, a Rab7 GTPase-activating protein (GAP), that stimulates Rab7 GTP hydrolysis for Rab7
inactivation. Importantly, neuronal TBC1D15 deficiency recapitulated excessive AV-Mito tethering coupled with
mitochondrial deficits. Overexpression of TBC1D15 in cultured tauopathy neurons reversed such AV-Mito
contact release defects, leading to reduced AV accumulation and improved mitochondrial function. Based on
these studies, we hypothesized that TBC1D15 deficiency causes AV-Mito contact hyper-tethering, which
hampers AV retrograde transport-mediated removal of p-tau-loaded AVs from synaptic terminals and
triggers mitochondrial defects, thereby contributing to the pathogenesis of tauopathy. Therefore,
TBC1D15 overexpression reverses autophagy and mitochondrial deficits and attenuates tauopathy-
related pathologies. Tau mouse models with TBC1D15 overexpression will be carefully characterized. We will
determine the mechanisms underlying TBC1D15 reduction in tauopathy and explore how AV-Mito contact
release deficiency contributes to autophagy failure and mitochondrial defects in tauopathy. The successful
completion of this study will advance the understanding of a critical early step in tauopathy pathogenesis and
may provide new molecular and pharmacological targets for drug development in tauopathy diseases including
AD and also have implications for studying other neurodegenerative disorders and aging in general.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) While the clinical outcomes of amyloid b (Ab)-based therapies for Alzheimer’s disease (AD) have been disappointing, pathologically phosphorylated tau and its associated neurofibrillary tangles (NFTs)-linked tauopathy clinically correlates better with dementia than amyloid plaques composed of Ab in Alzheimer’s disease. The dysfunction in both autophagy and mitochondria constitutes one of the most notable pathological features in tauopathy brains. The proposed studies aim to provide novel mechanistic insights into the role of autophagosome-mitochondria contact defects in tauopathy-linked pathologies and identify new molecular and pharmacological targets for treating diseases of tauopathy including Alzheimer’s disease and frontotemporal dementia (FTD).